Core--Biostatistics and Data Management

The objective of the Biostatistics and Data Management Core is to provide comprehensive biostatistical support to the Program Project grant "Prenatal Programming of Reproductive Health and Disease". The Core will: 1) provide assistance with the design of each study; 2) perform the data analysis; 3) develop statistical methods that enhance the ability to analyze the data from these experiments; and ensure study outcomes are analyzed correctly before being published.